Muller glia and retina regeneration

DESCRIPTION (provided by applicant): Despite structural and functional similarities between the teleost and mammalian retina, disease or injury of the mammalian retina leads to irreparable vision loss, while the injured teleost retina mounts a regenerative response that restores lost sight. Key to successful regeneration is Muller glia (MG), which dedifferentiate and generate retinal progenitors that can regenerate all major retinal cell types. In contrast, mammalian MG responds to retinal injury by reactive gliosis that is accompanied by hypertrophy;rarely do these cells re-enter the cell cycle and regenerate new neurons. These data suggest that a key difference between the regenerative responses of fish and mammals is the ability of MG to dedifferentiate following retinal injury. We propose that an understanding of the mechanisms by which MG dedifferentiate and generate a proliferating population of retinal progenitors will suggest novel strategies for stimulating this process in mammalian MG. Because zebra fish mount a robust regenerative response following retinal injury, they provide a useful model system for uncovering these mechanisms. This proposal focuses on uncovering secreted signals and receptors that stimulate MG dedifferentiation, mechanisms by which these signals are transmitted to the genome and mechanisms underlying proliferation of MG-derived progenitors. In addition, new zebra fish models have been created to test whether ablation of any retinal cell type is sufficient to induce MG dedifferentiation and retina regeneration and if any cells can compensate for loss of MG during retina regeneration. These studies should lead to novel strategies for inducing MG dedifferentiation and retina regeneration in mammals which can be applied to repairing a damaged or diseased human retina. PUBLIC HEALTH RELEVANCE: Human retinal diseases and injury often lead to irreparable blindness. Muller glia represents a potential source of retinal stem cells for repair of the damaged and diseased human retina. Uncovering the mechanisms underlying MG dedifferentiation in zebra fish may suggest novel strategies for inducing this process in humans and thus lead to repair of damaged and diseased human retinas.

Public health relevance
Human retinal diseases and injury often lead to irreparable blindness. Muller glia represents a potential source of retinal stem cells for repair of the damaged and diseased human retina. Uncovering the mechanisms underlying MG dedifferentiation in zebra fish may suggest novel strategies for inducing this process in humans and thus lead to repair of damaged and diseased human retinas.